Spontaneous Organization of Phenotypes during Collective Migration

Project Summary
Bacteria live in structured communities where coordinated interactions between individuals often result in
collective behaviors beneficial to the population. At the same time, even isogenic bacteria display phenotypic
heterogeneity, which diversifies individual behavior and enhances the resilience of the population in unexpected
situations. Understanding how the interplay of diversity and collective behavior contributes to spatial organization
and function in cell populations is a fundamental problem in cell biology that has been difficult to tackle
experimentally and theoretically because of difficulties in measuring and modeling processes at multiple scales.
Here we focus on how phenotypic diversity in motility and chemotactic ability contributes to the spatial
organization and phenotypic composition of a population of bacteria as it migrates through diverse environments.
Our starting point is the recent discovery by us and others that when chasing traveling fronts of attractant
generated by their own consumptions, bacteria spontaneously sort themselves along the traveling gradient: high-
performing phenotypes localize at the front where the signal (gradient steepness) is weaker and low-performing
phenotypes at the back where the signal is stronger but the risk of falling behind is higher. Thus, a leader-follower
organization of the phenotypes emerges, even in isogenic populations, with leaders driving the migration and
followers falling off and colonizing space behind the moving front.
These observations raise the following basic questions: 1) How do phenotypes reorganize themselves when the
population encounters a different environment where the most performant phenotype is now different? What
does that tell us about the capacity of a single genotype to navigate as a group through multiple environment?
2) To what extent can cell growth partially compensate for the leakage of cells and how does this affect the
phenotypic composition and organization of the migrating population? 3) To what extent does the spatial sorting
of motility and chemotaxis phenotypes seed spatial organization of virulence factors that tend to be coregulated?
To address these questions, we will develop new mathematical models of collective bacterial migration that
include three key ingredients: a continuum of phenotypes, cell growth, and diverse environments. To constrain
models, we will use E. coli chemotaxis because it is well-characterized, positioning us to discover general
principles, and P. aeruginosa, an opportunistic pathogen that shares some features of the E. coli chemotaxis
pathway but expresses two different stator systems necessary for migration through different environments.

Public health relevance
Project Narrative Chemotaxis enables pathogens and commensals to rapidly expand in space and to move en masse towards preferred sites of infection or colonization. At the same time, phenotypic diversity in motility and chemotactic abilities causes isogenic cells to spontaneously sort spatially as they migrate in a group, with some phenotypes leading the migration and others falling off and colonizing space behind. This project will examine (1) how leading phenotypes change and the population reorganizes when it encounters different environments, (2) how this dynamic reorganization of phenotypes might serve as an adaptation mechanism for one genotype to navigate multiple environments, and (3) how the priority effect (who arrives first, second etc…) introduced by this spatial ordering influences the spatial organization of other traits that are coregulated with chemotaxis, such as virulence factors. 1